Developing a novel approach to the nonhuman primate placental organoid model

PROJECT SUMMARY
The placenta is the regulatory and exchange barrier that functions to balance maternal nutritional supply
with fetal metabolic demands during pregnancy. Inadequate placental development and subsequent
dysfunction results in a range of adverse fetal and maternal outcomes. The first trimester is a crucial time for
the establishment of appropriate placentation, yet our current knowledge of first trimester development is
inadequate, and understanding of placental development and function throughout pregnancy is impeded by the
lack of access to longitudinal samples and a lack of suitable in vitro model systems.
In early placental formation, trophoblast cells, a specialized placental stem cell, differentiate into two types:
extravillous trophoblast cells (EVTs), which invade the maternal spiral arteries, anchor the placenta in the
decidua and are critical for forming a strong vascular foundation for a fully functioning placenta. The
syncytiotrophoblast (SYN), a multinucleated epithelium, serves as the maternal-fetal exchange surface. Despite
their importance, understanding the regulation of trophoblast cell lineage specification and differentiation has
been hindered by the lack of appropriate cellular model systems and access to placental tissue from early
gestation. Organoids are self-organizing and propagating 3-dimensional (3D) culture model systems that are
derived from stem cells. They can be directed to grow ex vivo in to mini organ structures by manipulating growth
conditions and providing developmental cues that drive phenotype-specific cell development. Recently, a first
trimester human trophoblast organoid system has been developed. However, the placenta is a fetal tissue which
leads to ethical concerns associated with the use of termination samples in research. The nonhuman primate
(NHP) offers a solution to this problem. We propose to generate a first trimester NHP organoid model, and test
the feasibility of obtaining first trimester placenta samples through the use of ultrasound-guided chorionic villous
sampling (CVS), thus avoiding the need for termination. A second challenge to the use of organoids for in vitro
experiments is cell polarity. Specifically, use of a matrix suspension typically orientates the apical cell surface to
the center creating an `inside out' organoid structure, thus limiting their utility in placental barrier studies.
Importantly, recent advances in other organoid systems have demonstrated the ability to alter the composition
of the extracellular matrix to convert 3D structures to 2D cell layers.
The overarching premise of this proposal is to develop a new ex vivo tool to expand our understanding of
early placental development and function in a translational animal model. Within the scientific objectives we will
utilize CVS to obtain placental biopsies, in addition to whole placental tissue collection for organoid preparations
to directly compare the two sampling methodologies. Organoids will be induced to differentiate, and culture
conditions manipulated to alter cell polarity. This novel work will establish a pipeline for previously inaccessible
pathways for the study of normal and perturbed placental function.

Public health relevance
PROJECT NARRATIVE The placenta is the key mediator of maternal-fetal exchange during pregnancy. Understanding of placental function during the critical period of early placental development in humans is hindered by ethical and practical considerations for tissue accessibility. The objective of this project is to develop an ex vivo trophoblast organoid resource to assess placental development and function during the first trimester in a translational animal model.